Neural mechanisms of visuomotor transformations in larval zebrafish

Project Abstract
To survive in dynamic environments, animals utilize continuous sensory information to drive precise and
coordinated motor behavior. For instance, to catch a flying ball, one must reach with a targeted, discrete arm
movement. Therefore, the neural networks processing visual information must transform these continuous
motion cues into distinct motor commands to achieve locomotion with appropriate speed, vigor, and duration.
So far, there has been no single-cell resolution and mechanistic characterization of these circuits in vertebrates
due to the overwhelming size of the mammalian brain. In this proposal, I will leverage the optically and genetically
accessible larval zebrafish (Danio rerio) for cellular level dissection of the visuomotor circuit underlying a visually
guided behavior, the optomotor response (OMR). During the OMR, zebrafish stabilize their body’s position by
compensating perceived optic flow via discrete locomotion events (i.e. bouts), consisting of undulating tail
movements for short periods followed by passive glide phases. Previous behavioral and neural imaging studies
have characterized motion-processing neural circuits across the brain, including the retinorecipient pretectum
(Pt). Recently, we have implemented these circuits into quantitative models and a physics-based
neuromechanical simulation, simZFish, which allows for simulated OMR behavior experiments with biologically
derived neural circuits. Yet, these virtual whole-brain OMR circuit models lack clarity in the functional circuit
architecture and mechanisms that transform continuous visual motion encoded by the Pt into discrete movement.
Here, I hypothesize that specific motion-selective Pt neurons drive the activation of a recurrent inhibitory bout-
generating circuit, composed of specific midbrain spinal projection neurons, excitatory hindbrain neurons, and
hindbrain inhibitory neurons. To determine the functional neural circuit that transforms visual motion into motor
commands, I will use in vivo volumetric two-photon imaging with precise 3D holographic optogenetic
photostimulation to map cellular functional connections across brain regions between motion responsive Pt
neurons and the midbrain cells that initiate bouts (Aim 1). To determine how continuous visual motion is
converted into discrete locomotor events, I will investigate how the midbrain cells recruit specific excitatory and
inhibitory hindbrain neurons using the same all-optical techniques with simultaneous tail tracking (Aim 2). Results
from both aims will update the simZFish neural circuit and then tested in virtual experiments to validate these
findings. Using integrative all-optical, behavioral, and neuromechanical approaches, this proposal aims to
provide insights into how single neurons transform sensory information into motor commands and general
principles of vertebrate locomotion control. Ultimately, my long-term goal is to comprehensively understand how
neurons compute information across brain regions to generate movement for future applications to develop
physiologically accurate prosthetics and treat motor neurodegenerative diseases.
\

Public health relevance
Project Narrative Brain-wide vertebrate visuomotor circuits transform visual information into discrete behaviors. This proposal aims to reveal the functional mechanisms of visual motion transformation into motor commands by leveraging the experimental advantages of the larval zebrafish, integrating all-optical imaging and optogenetic technologies with neuromechanical simulations. Results will provide insights into how neurons integrate information to generate specific actions at the cellular level, general principles of vertebrate locomotion control, and inform future treatments of motor neurodegenerative diseases via physiologically accurate prosthetics.